LncRNA MERRICAL, macrophage chemotaxis, and diabetes-associated atherosclerosis

Atherosclerosis, a chronic arterial disease, is markedly accelerated in individuals with diabetes, accounting for
a 2- to 4-fold increased risk of ischemic cardiovascular events. One of the hallmarks in this process involves
the recruitment and accumulation of intimal macrophages, a process that is more pronounced in diabetes than
without diabetes. The presence of pro-inflammatory macrophages facilitates the progression of atherosclerosis
and impairs the ability of lesions to regress despite optimal medical therapy. Therefore, modulating
monocyte/macrophage chemotaxis and accumulation in the vessel wall may provide a novel therapeutic
approach to limit atherosclerotic progression and facilitate regression.
Long non-coding RNAs (lncRNAs) are an emerging class of regulators of epigenetic modifiers, RNA, or
protein-coding genes that has garnered attention for impacting diverse biological processes relevant to
atherosclerosis. However, the identity and roles of specific lncRNAs within atherosclerotic lesions, especially in
diabetes, are not well defined. Using RNA-Seq profiling to identify lncRNAs derived specifically from the
atherosclerotic intima, we identify the lncRNA MERRICAL (Macrophage-Enriched lncRNA Regulates
Inflammation, Chemotaxis, and AtheroscLerosis (MERRICAL). MERRICAL was the highest expressed lncRNA
with a 249% increase concomitant with atherosclerotic progression under a high fat sucrose-containing (HFSC)
diet and decreased with regression after a high cholesterol diet, but not after a HFSC diet. MERRICAL is a
macrophage-enriched and nuclear-specific lncRNA. Our preliminary data demonstrate that delivery of inhibitors
to MERRICAL in LDLR-/- HFSC-fed mice strongly reduced lesion size by 86%, independent of effects on
circulating lipid profile, but rather by decreased macrophage accumulation in lesions. Preliminary studies show
that MERRICAL in-cis regulates its neighboring genes Ccl3 and Ccl4 and macrophage chemotaxis mediated
via interaction with a complex of the histone modifying enzyme H3K4me3. In addition, MERRICAL knockdown
functions in-trans to regulate IL-1b-associated inflammasome signaling. These observations provide the central
hypothesis that MERRICAL deficiency, via regulatory effects on H3K4me3 and macrophage chemokines and
IL-b inflammasome signaling, reduces macrophage chemotaxis, lesional macrophage inflammatory signaling,
and suppresses diabetes-associated atherosclerosis. To address this further, in Aim1 we examine the role of
MERRICAL and the in-cis regulation of CCL3/CCL4 in macrophage chemotaxis and in-trans regulation of IL-
1b-associated inflammatory signaling; in Aim2, we assess how alterations of MERRICAL expression affects
recruitment of lesional macrophages on lesion progression and regression in vivo; and in Aim3, we examine
the role of the MERRICAL-H3K4me3 signaling axis in human cells and atherosclerotic lesions. Our studies will
address a major gap in our understanding of lncRNAs in atherosclerosis and diabetes and inform how
MERRICAL-mediated control of lesional macrophages may provide new targets for therapy.

Public health relevance
Narrative: Accumulation of pro-inflammatory macrophages in the vessel wall is a hallmark observed in atherosclerosis, an effect that is markedly accelerated in diabetes. Our preliminary studies indicate that a novel macrophage-enriched long non-coding RNA (lncRNA) termed MERRICAL may act to control lesion formation within the vessel wall by regulating macrophage accumulation and pro-inflammatory signaling pathways. The proposed studies will provide a detailed understanding underlying the function of this lncRNA, its interactors, and how to leverage therapeutic manipulation of this lncRNA and its interactors with the goal of developing novel lncRNA-based therapies for the treatment of the accelerated atherosclerotic disease in diabetes.